Alcohol-induced decreases in REM sleep: GABA-A receptor subtypes

Project Summary
There is a high prevalence of sleep complications among individuals seeking treatment for alcohol use disorder
(AUD). Alcohol consumption induces sleep disturbances, and in turn, disrupted sleep predisposes AUD patients
to continued alcohol use, poor treatment response, and relapse. In addition to affecting different stages of sleep
architecture, alcohol has been shown to decrease rapid eye movement (REM) sleep, and the mechanisms by
which these reductions occur remain unclear. Identifying the pharmacological mechanism by which alcohol
suppresses REM sleep may provide a potential target for treating sleep disturbances observed in AUD patients
and improving overall treatment outcomes. REM sleep is generated and maintained by the interplay of several
neurotransmitter systems in the brainstem, forebrain, and hypothalamus. One key neurotransmitter is γ-
aminobutyric acid (GABA), which also is a critically important mediator of alcohol's behavioral effects. We
hypothesize that alcohol-induced REM sleep suppression is driven by alcohol's positive modulation of
α1- and/or α5-GABAA receptor (GABAAR) subtypes and, further, that negative modulation of these
subtypes will attenuate alcohol-induced REM sleep suppression. We will use electroencephalographic
(EEG) and electromyogram (EMG) recordings and subtype-selective GABAAR modulators to determine the role
of specific GABAAR subtypes in alcohol-induced suppression of REM sleep. The overarching hypothesis will be
evaluated in three Specific Aims. In Aim1, we will evaluate sleep-wake states and EEG spectral power in male
and female Sprague Dawley rats following administration of alcohol and subtype-selective GABAAR positive
modulators. We predict alcohol will induce changes in sleep-wake states and EEG spectral power that mimic
changes produced by non-selective positive GABAAR modulators. We further hypothesize that α1- and/or α5-
GABAAR positive modulators will elicit unique changes in sleep-wake states and EEG spectral power that include
a reduction in REM sleep. In Aim 2, we will evaluate the extent to which α1-GABAAR subtypes mediate alcohol-
induced REM sleep suppression. We predict that pretreatment with a negative α1-GABAAR modulator will
prevent alcohol-induced reductions in REM sleep and that a positive α1-GABAAR modulator will exacerbate
alcohol-induced reductions in REM sleep. Finally, in Aim 3, we will evaluate the extent to which α5-GABAAR
subtypes mediate alcohol-induced REM sleep suppression. We predict that pretreatment with a negative α5-
GABAAR modulator will attenuate alcohol-induced reductions in REM sleep and that a positive α5-GABAAR
modulator will aggravate alcohol-induced reductions in REM sleep.

Public health relevance
Project Narrative The prevalence of sleep complications, such as suppression of rapid eye movement (REM) sleep, in alcohol use disorder (AUD) patients can predispose patients to continued alcohol use and contribute to poor treatment response. Our studies will yield key information on the pharmacological mechanisms involved in alcohol-induced REM sleep suppression. Ultimately, our research will aid in the identification of new therapeutic targets aimed at attenuating alcohol-induced reductions in REM sleep and improving overall treatment outcomes for AUD patients.